Identifying the Role of the Periaqueductal Gray in Mediating Traumatic Brain Injury Induced Thermal and Mechanical Hypersensitivity Reduction After Green Light Exposure

Mild traumatic brain injury (mTBI) is the most common traumatic brain injury affecting military personnel. mTBI
is associated with several neurological symptoms that correlate with neuroinflammation. One of the neurological
symptoms associated with mTBI is pain. mTBI-induced pain may be challenging to manage in some cases.
Therefore, opioids may be used to control such pain. However, opioids have significant side effects, especially
when used chronically, which may lead to substance misuse. The opioid crisis has demonstrated the need for
complementary methods for pain control. Because of the association between mTBI and substance misuse,
there is a significant need for alternative/complementary approaches to opioids to treat pain, especially in treating
the pain associated with mTBI.
mTBI induces inflammation as manifested by increased inflammatory cytokines such as IL-6 and TNF-α in the
central nervous system (CNS) and plasma. Two sources for these cytokines are microglia and astrocytes, both
of which become activated after mTBI, contributing to the development of pain. Decreasing the levels of pro-
inflammatory cytokines and increasing the levels of anti-inflammatory cytokines may promote decreased mTBI-
induced pain. A therapy that reduces microglia and astrocytes' activation and decreases the neuroinflammatory
environment would be ideal for both military personnel and veterans.
Phototherapy is used for multiple medical conditions, but few studies investigated the effects of phototherapy on
pain. We have shown that green light exposure (GLED) was antinociceptive by reversing thermal and mechanical
hypersensitivity in rats. In humans, we have demonstrated that GLED decreased chronic pain and sleep
disturbances in fibromyalgia and migraine, suggesting that GLED therapy applies to humans despite differences
in the visual systems between rodents and humans. Furthermore, we have shown that GLED reversed the
hypersensitivity associated with mTBI in two different TBI mice models. We also demonstrated that GLED
reversed postsurgical thermal and mechanical hypersensitivity by increasing anti-inflammatory IL-10 levels in
the cerebrospinal fluid (CSF) while decreasing pro-inflammatory IL-6. GLED reversal of thermal and mechanical
hypersensitivities was attenuated when the periaqueductal gray (PAG), a crucial pain-modulating center, was
blocked, suggesting that GLED may be inhibiting the descending pain-facilitatory pathway.
Therefore, it is reasonable to postulate our hypothesis that GLED visual exposure will attenuate mTBI-
induced hypersensitivity by inhibiting the descending pain-facilitatory pathway.
We will use three specific aims (SA) to investigate our hypothesis. SA1 will explore the potential translation of
GLED therapy by exploring its ability to reverse the mTBI-induced thermal and mechanical hypersensitivities in
multiple rodent sexes and species. SA2 will evaluate the effects of GLED on modulating glial cells and the effects
on neuroinflammation while assessing the contribution of microglia and astrocytes to the development of mTBI-
induced hypersensitivities. SA3 will elucidate how GLED interacts with the descending pain-facilitatory pathway
Short-term benefits of completing our proposed studies include elucidating the neuronal circuitry mediating the
effects of GLED and characterizing the effects of GLED on the PAG, which may bring GLED therapy a step
closer to clinical implementation. The long-term benefits include the innovative development of a regenerative
medicine approach using the minimally invasive and affordable GLED therapy for mTBI and other conditions that
involve CNS inflammation and decreasing the need for opioids.

Public health relevance
Mild traumatic brain injury (mTBI) is the most common traumatic brain injury affecting military personnel. mTBI may become a long-term debilitating condition associated with inflammation in the central nervous system (CNS), manifesting as headache, diffuse pain, cognitive impairment, and sleep disturbance. Opioids are a poor option for managing mTBI and other chronic pain conditions because of significant side effects, paradoxical pain, and misuse potential. We have shown that green light therapy (GLED) is effective in several pain conditions, including mTBI. GLED is mediated through the visual system, which projects to the periaqueductal gray (PAG), one of the primary control centers for pain modulation. This proposal seeks to elucidate the role of GLED in modulating the pain descending-facilitatory pathway starting from the PAG using a validated mTBI model. This knowledge will facilitate the development of an innovative regenerative medicine application using GLED to address the consequences of mTBI.